Translational center for kidney microphysiological systems to improve drug safety and efficacy

ABSTRACT - Overall
The overall goal of the University of Washington Translational center for kidney microphysiological
systems to improve drug safety and efficacy is to expand upon kidney tissue chip developmental work
our team has accomplished over the past decade, in order to qualify these microphysiological systems as
drug development tools for specific Contexts of Use. Despite marked recent advances in our understanding
of the physiology and pathophysiology of the human kidney in health and in disease, there are relatively few
drugs that are proven to be safe and effective therapies for kidney diseases. Historically, the structural,
functional and physiological complexity of the kidney has contributed significantly to the high rate of failures
in therapeutic drug development. The complex multicellular architecture and unusual triad of physiological
processes characterized by glomerular filtration, tubular secretion and tubular reabsorption, have limited the
ability of animal models to recapitulate the diversity of etiologies, mechanisms, and heterogeneous clinical
manifestations of most human kidney diseases. The limitations resulting from extrapolating animal model
data to human kidney diseases constitutes a major barrier to developing new therapies. Until recently there
has been a lack of human in vitro models that recapitulate critical aspects of kidney function or assess
reparative mechanisms in response to injury. This is in part because microfluidic flow is so essential to kidney
structure and cellular function. In response to this critical unmet need, our group has pioneered the
development of ‘human kidney-on-a-chip’ microphysiological systems. Our in vitro on chip models
recapitulate critical aspects of kidney physiology, assess the mechanisms and response to injury, and can
test reparative mechanisms, all of which can substantially enhance successful drug development that is
needed to improve the lives of people living with kidney diseases

Public health relevance
PROJECT NARRATIVE - Overall Innovative safe and effective new treatments are needed to improve the lives of people living with kidney diseases. The development of tissue chips provides a path forward to improve the drug development pipeline. The overall goal of the University of Washington Translational center for kidney microphysiological systems to improve drug safety and efficacy is to expand upon already completed work, in order to qualify these systems as useful drug development tools.